5 DAY INFUSIONAL ETOPOSIDE PLUS MEGESTROL ACETATE--PHASE I CLINICAL/PHARMACOLOGY

This is a Phase 1 study of the effect of megestrol acetate, a potential inhibitor of p-glycoprotein, on the kinetics and toxicity of etoposide. We continue recruiting patients for this study.